Mitochondrial transfer from astrocytes to glioblastoma cells drives tumor growth

PROJECT SUMMARY: Glioblastoma (GBM) is the most common primary brain tumor and is incurable,
invariably recuring after standard therapy with surgery, chemotherapy and radiation. GBM cell heterogeneity
allows it to thrive in varying adverse conditions in the tumor microenvironment (TME), including therapeutic
insults, hypoxic stress, and immune attack. Interactions with cells in the TME—including neurons, glia,
endothelium, and immune cells—support this heterogeneity and plasticity, contributing to the tumorigenicity,
resistance, and recurrence of this deadly disease. Given the limited efficacy of standard treatment approaches
in GBM, there is an urgent need to decipher and therapeutically target protumorigenic interactions in the TME.
There is evidence that glioma cells form an interconnected network that facilitates the exchange of mitochondria,
which are the main energy-producing organelle and regulate metabolism, proliferation, and epigenetics. There
is also early evidence that mitochondria can be transferred from non-malignant cells to cancer cells. However,
there is limited understanding of mitochondrial transfer dynamics from the TME to GBM; the
mechanisms that govern this transfer; and the downstream effects of transfer on recipient GBM cells.
Addressing this knowledge gap is vital for designing therapeutics that target this interaction. I hypothesize that
mitochondria are transferred from neural cells in the TME to GBM by the action of fusogenic proteins, and that
this transfer drives tumorigenicity by metabolic and epigenetic reprogramming. Specific Aim 1 will test the
hypothesis that astrocytes are the predominant mitochondrial donors, and that transfer is mediated by fusogenic
proteins termed syncytins. I will investigate mitochondrial donor identity using transgenic mice and cell models
expressing lineage-specific mitochondrial fluorophores. I will test how knockdown and overexpression of
syncytins affects rate and protumorigenic effects of transfer from astrocytes to GBM cells. Specific Aim 2 will
test the hypothesis that mitochondrial transfer from astrocytes drives GBM proliferation and tumorigenicity by
metabolic and epigenetic reprogramming. I will investigate how transfer of ATP-synthase with mitochondria
drives tumorigenicity; how mitochondrial transfer results in plasticity of GBM heterogeneity by global metabolic
reprogramming; and how mitochondrial transfer drives proliferation by epigenetic reprogramming and increased
chromatin accessibility. Career development and long-term objectives: I will receive training in cancer
metabolism and brain tumor research, and interact with a mentorship committee of experts from both fields. This
training and the proposed studies are invaluable for my career goal of establishing an independent research
program with the following long-term objectives: (a) elucidate molecular mechanisms of how mitochondrial
transfer reprograms metabolism and epigenetics, (b) develop therapeutics targeting mitochondrial transfer and
its downstream effects, (c) investigate how metabolic interactions in the TME impact other treatment modalities,
including chemotherapy, radiotherapy, and immunotherapy in GBM and other cancers.

Public health relevance
PROJECT NARRATIVE Complex interactions among neurons, glia, immune and endothelial cells in the microenvironment drive the progression, treatment resistance, and recurrence of glioblastoma (GBM), an incurable primary brain tumor. The short-term goal of this project is to elucidate how a poorly understood microenvironmental interaction—namely, mitochondrial transfer from neural cells to GBM—drives tumorigenicity, focusing on astrocytes as predominant organelle donors. The long-term goal and future studies will (a) investigate the differential mechanistic role of mitochondrial transfer from diverse brain cell lineages, (b) interrogate how mitochondrial transfer influences spatio-temporal heterogeneity in primary and recurrent patient GBM specimens, and (c) develop therapeutics targeting molecular mediators of this protumorigenic interaction.